Enhancing Research Relevance and Impact Through Participant and Provider Engagement in the All of Us Research Program

Pyxis Partners employs a strategic, engagement-centered approach that prioritizes
collaboration and long-term sustainability. Our engagement strategy encompasses both
community and researcher engagement activities, facilitating and implementing tailored
initiatives that bridge the gap between different parties invested in health research. This project advances public health by strengthening engagement strategies that increase awareness of and participation in the All of Us Research Program, among researchers and community members alike. Through targeted messaging, expanded visibility, and trusted partnerships, Pyxis Partners and collaborators will continue to grow public trust, improve research accessibility, and contribute to the data resource.

Public health relevance
Pyxis Partners employs a strategic, engagement-centered approach that prioritizes collaboration and long-term sustainability. Our engagement strategy encompasses both community and researcher engagement activities, facilitating and implementing tailored initiatives that bridge the gap between different parties invested in health research. This project advances public health by strengthening engagement strategies that increase awareness of and participation in the All of Us Research Program, among researchers and community members alike. Through targeted messaging, expanded visibility, and trusted partnerships, Pyxis Partners and collaborators will continue to grow public trust, improve research accessibility, and contribute to the data resource. These efforts will ultimately enhance research relevance and impact.